Administrative Core

SUMMARY – CORE A
Core A is the administrative core, with the following broad objectives: First, Core A will maintain and strengthen
the internal structure of the PPG research team. The goal will be to work with PPG investigators to develop
priorities and support adherence to these priorities, facilitate planning and implementation of meetings, allow
for data transfers, and ensure that members of the team collaborate effectively with others, thus avoiding
duplication of effort or poor communication. Second, Core A will ensure that all members of the research team
keep up with cross-disciplinary developments and methods, and that they maintain a strategic focus on future
research developments. There are continuous ongoing developments in the large number of disciplines that
are either central to, or touch on our research; it can be challenging to maintain knowledge in these areas. To
respond to this, Core A will continue to host research retreats, which will be attended by both PPG key
personnel and non-PPG researchers with innovative work in related areas. Core A will also oversee the
continuation of an external advisory board to provide input on the future directions of the PPG, but with new
membership, including scientists with expertise in Alzheimer’s disease and related dementias (ADRD); health
care delivery and health equity; and patient, family, and community representatives. Third, Core A will oversee
the wide distribution of research results and will foster connections across institutions and disciplines. The
goals will be to disseminate current research through conference presentations and publication in peer-
reviewed journals in relevant disciplines, to provide information about the use of claims data to the wider group
of healthcare researchers, to continue interactions with authorities and experts on health care policy, to
maintain a website for dissemination of Dartmouth data, and to continue the PPG’s support of Dartmouth’s
Dataverse website to ensure reproducibility and rigor in research. Finally, Core A will create a platform to
consider and approve funding for pilot projects that encourage new and innovative research. This PPG has
budgeted funds to encourage pilot studies related to the PPG research agenda and targeted support for
developing supplement applications from scientists historically underrepresented in NIH-funded research.